Core A: Administrative Core

ABSTRACT:
The success of a P01 grant is highly dependent on the integration of the projects through a strong series of
Shared Resource Cores. The Administrative Core (Core A) is proposed for renewal for the expressed purpose
of providing leadership, administrative support and a framework of interaction for the planning, coordination,
implementation and ongoing review of the individual research projects, cores and program of clinical trials to
be conducted under the proposed P01. Core A will foster the scientific and clinical objectives of the individual
projects and the P01 as a whole by conducting periodic meetings with the participating Project and Core
Leaders to develop strategic plans and consensual decisions regarding program development and organizes
periodic reviews of research progress and productivity by the Internal Executive Committee and the External
Advisory Board. The core also maintains and facilitates communication between investigators in the individual
projects and cores through regular conferences and research-in-progress presentations. Lastly, this Core
provides fiscal management services for the projects and cores of the P01 and oversees all communication
related to the P01 with the NCI. The Specific Aims for Core A are: provide organization and leadership for the
P01 (Aim 1); provide general administrative and financial management for the individual research projects and
cores (Aim 2); facilitate intra-programmatic interactions and communications through research conferences and
periodic scientific reviews (Aim 3) and coordinate and provide oversight of scientific and clinical activities of the
program (Aim 4). The Administrative Core will provide the necessary organizational support and leadership to
aid the Project and Core Leaders in the accomplishment of the overall goal of the P01: to study both in mouse
and man the mechanisms underlying the major complications of allo-HCT, including infections, GVHD and
relapse, and develop novel therapeutic strategies to be tested in clinical trials in allo-HCT patients.